Improving HIV and STI Prevention and Care for Venezuelan Sexual and Gender Minority Migrants in Lima, Peru

The Venezuelan refugee crisis is the largest recorded mass migration in Latin America with 20% of
Venezuela’s population displaced, primarily to Latin American countries. Venezuelan migrants face intersecting
forms of socio-structural disadvantage that negatively impact their health—e.g., precarious employment,
xenophobia and material deprivation. This displacement also strains chronically underfunded health care and
public services; including in Peru, a country of 33 million, which is the second largest host country in the region
with over 1 million Venezuelan migrants. These multi-level, systemic inequities perpetuate disadvantages
among migrants and specifically among sexual and gender minorities (SGM). These unique biosocial
stressors faced by Venezuelan sexual and gender minority migrants (VSGMM) require an urgent and
tailored response to prevention and care services for HIV and other sexually transmitted infections
(STIs); yet their needs remain understudied.
SGM face individual and structural social conditions (e.g., high levels of violence, stigma, criminalization, and
housing instability) and biomedical conditions (e.g., mental illness and substance use), can increase
vulnerability to HIV/STI. Globally, SGM migrants are disproportionally at risk for HIV/STIs compared to non-
SGM migrants as they are at the nexus of migration and SGM health disparities. Migrant populations face
barriers to health care and social services access including stigmatization, discrimination and identity
documentation requirements; these barriers are compounded among migrants engaged in sex work, who are
frequently SGM. Venezuelan migrants living with HIV face heightened disparities; lower rates of viral
suppression and higher rates of treatment non-adherence and abandonment compared to host countries’
citizens living with HIV. There is urgent need to assess the multi-level social and biomedical
vulnerabilities that place VSGMM at risk for HIV/STI. Thus, we will apply Syndemic theory to assess the
heightened risk of HIV/STIs acquisition and lower care engagement among adult VSGMM living in Peru and
inform the future design and implementation of an integrated care and social prescribing intervention, providing
for the HIV/STI needs of VSGMM and also linking them to with social services, to address both social and
biomedical vulnerabilities. This two-year exploratory study will:
Aim 1. Apply Syndemic Theory to explore how social vulnerabilities related to migration and SGM status drive
unique HIV/STI prevention and care needs among VSGMM in Peru using qualitative research methods.
Aim 2. Characterize the prevalence of HIV and STIs and identify syndemic clusters of biomedical and social
factors associated with HIV/STI among VSGMM using a bio-behavioral survey and latent class analysis.
Aim 3. Inform a novel intervention based on identified drivers of HIV/STI prevalence and care needs,
migration, and social vulnerabilities including social prescribing and addressing their HIV/STI care needs.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Silva-Santisteban, A. Project Narrative Venezuelan migrants to Peru remain in a state of uncertainty and sexual and gender minorities among this group are in particular need of attention and care. In this study, we take our past experience with working with SGMs and migrants to explore the sexual health and HIV/STI prevention and care needs of this population. Our research will be conducted in conjunction with an HIV/STI clinic in Lima, Peru and will apply syndemic theory to qualitatively and quantitatively explore the sexual health needs of VSGM. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page